Catheter Cap with Anti-biofilm Luminal Insert

The goal of this work is to develop a catheter end cap with an antimicrobial luminal insert to reduce risk of blood
stream infections (BSI) in hemodialysis (HD) patients. The Gatekeeper™ antimicrobial barrier cap (GCAP) acts
as a barrier and delivery device to kill infection-causing microorganisms inside hemodialysis (HD) catheter hubs.
Infections are the second leading cause of hospitalization and death in HD patients with 70% of all BSI due to
catheter use.1,2 Catheter related BSI necessitate catheter locking with high dose antibiotics, removal and
replacement of the catheter at a new site, or exchange of the catheter for a new one which preserves the venous
site but with increased risk of infection recurrence.3 Replacement of long-term catheters is a major problem with
high morbidity, high costs and risk for vein damage in patients where it is critical to preserve insertion sites.
GCAP can reduce infections, excessive antibiotic use, and the need for catheter replacement.
The proposed cap is a short (5 cm) guidewire that extends from the end cap and is inserted in the catheter
extension line upon cap placement on the hub. This guidewire is loaded with a novel antimicrobial peptide called
ASP-2 that has broad spectrum efficacy against infection causing microbes and their associated biofilms. When
screwed into place, the peptide is released into the lock solution eliminating microbes and preventing catheter
biofilms from accumulating. Standard practice dictates replacement of caps with each hemodialysis session,
typically once every three days. The caps replenish ASP-2 with each access event to provide protection over
the catheter lifetime, overcoming the limited activity duration of antimicrobial coated catheters.4
This Phase I project builds on strong existing data establishing the safety and broad-spectrum activity of ASP-2,
including its capacity to eradicate biofilms on device surfaces and under conditions relevant to vascular access.
The objectives are to (1) develop the coating composition and process to apply ASP-2 to end caps, (2)
manufacture and characterize prototypes, including ASP-2 delivery and stability to sterilization, (3) demonstrate
efficacy in a challenging ex vivo hemodialysis model, and (4) verify end caps meet minimal safety requirements
by measuring particulate development, metal ion leaching, and the strength of the wire to cap bond.
The proposed caps are expected to provide a safe and simple solution that does not require additional steps or
nursing time to reduce infection risks. There is a large and growing market for infection control consumables in
the setting of dialysis and vascular access. GCAP has substantial commercial potential and will benefit multiple
stakeholders including patients, hemodialysis centers, hospitals, and insurers.

Public health relevance
PROJECT NARRATIVE Patients that require hemodialysis are at increased risk for blood stream infections, largely due to long term dependance on vascular access and a high prevalence of central venous catheter (CVC) use. The results of this work will improve safety and reduce the cost of delivering hemodialysis to patients with end stage renal disease by preventing catheter related infections. This will be accomplished by developing a simple to use catheter end cap that functions as an antimicrobial barrier and delivery device to kill infection-causing microorganisms inside hemodialysis catheter hubs.